Molecular Control of Plasmacytoid Dendritic Cell Development and Function

ABSTRACT
Plasmacytoid dendritic cells (pDCs) rapidly secrete type I interferon (interferon α/β, IFN) in response to
virus-derived nucleic acids, facilitating both innate and adaptive antiviral responses. Conversely, aberrant
IFN production by pDCs is associated with autoimmune diseases, establishing pDCs as important emerging
therapeutic targets. The overall goal of this project is to elucidate the molecular control of pDCs lineage,
including its development, homeostasis and function in various immune responses. In the previous award
cycles, we have identified E protein transcription factor TCF4 (E2-2) and several other factors as important
regulators of pDC development. The proposed work will build upon these findings to address major
unanswered questions in pDC biology. In Aim 1, we will use high-dimensional single-cell analysis methods
to characterize the stage and regulation of pDC lineage specification, as well as the functional heterogeneity
of mature pDCs. In Aim 2, we will use genetic approaches to dissect transcriptional control and regulation of
the unique IFN-producing capacity of pDCs. Collectively, the proposed studies should yield a
comprehensive molecular view of pDC development and function, paving the way for therapeutic
approaches focused on this cell type.

Public health relevance
NARRATIVE Plasmacytoid dendritic cells (pDCs) play an important role in immune responses to infection and in autoimmunity, and therefore represent attractive targets for novel immunoterapies. The proposed work aims to build a comprehensive molecular view of pDC development and function, paving the way for pDC- focused translational approaches in human diseases.